Rescue of Cul3 haploinsufficiency phenotypes with CRISPR-mediated Cul3 activation

SUMMARY
Rare and de novo single nucleotide variants (SNVs) and copy number variants (CNVs) are major risk factors for
Neurodevelopmental Disorders (NDDs). The majority of NDD-associated SNVs affect a single allele of a gene,
leading to haploinsufficiency. Correcting haploinsufficiency by increasing the expression level of the deficient
allele could provide an attractive strategy for NDDs treatment. A variant of CRISPR, CRISPRa (CRISPR
activation), offers the possibility to modulate the expression of endogenous genes by directly targeting their
promoters or enhancers. Here, we are proposing to apply CRISPRa to upregulate the levels of Cul3 ubiquitin
ligase, a high-confidence gene for NDDs. We have recently generated a haploinsufficient Cul3 mouse model.
Brain MRI found decreased volume of cortical regions starting from early postnatal development and persisting
into adulthood. Spatiotemporal transcriptomic and proteomic profiling implicated cytoskeletal and synaptic
defects as key drivers of Cul3 functional impact. Specifically, dendritic growth, filamentous actin puncta, and
spontaneous network activity measured by multielectrode arrays (MEA) were reduced in Cul3 mutant mice. Cul3
mutant mice also exhibited hyperactive behavior, along with social and cognitive deficits. We hypothesize that
upregulation of Cul3 dosage early in development with CRSIPRa will rescue some (or all) of the observed
phenotypes, and will lay the basis for general therapeutic interventions in NDDs. The goal of this project
is to demonstrate the feasibility of compensating for Cul3 haploinsufficiency by rebalancing neuronal, molecular,
cellular and network activity phenotypes. We will achieve this goal through the following Specific Aims: (1) To
evaluate rescue potential of cellular and molecular phenotypes in the Cul3+/- CRISPRa mice; (2) To evaluate
rescue potential of brain architecture and cognitive deficits in Cul3+/- CRISPRa mice. Our study will represent an
effective strategy for rebalancing Cul3 (and potentially other NDD genes) deficiency and correcting associated
phenotypes.

Public health relevance
NARRATIVE The goal of our study is to correct the phenotypes associated with Cullin 3 haploinsufficiency by activating Cul3 gene using CRISPR activation approach. Our study will help to outline a general therapeutic strategy for the treatment of neurodevelopmental disorders.